TREATMENT EVALUATION AND MANAGEMENT

The Treatment Evaluation and Management (TEaM) system is designed to provide clinical decision support, documentation of outcomes, and continuous quality improvement for behavioral healthcare treatment. TEaM provides several unique features: (1) seamless monitoring of patient progress within and across primary care, chemical dependency and outpatient mental health treatment settings; (2) multivariate severity adjustment; (3) detection of inconsistent and/or malingering response patterns; and (4) prediction of expected course of treatment using hierarchical linear modeling. All aspects of TEaM (administrative procedures; data collection, storage, analysis and reporting) will be fully automated to minimize administrative/respondent burden, maximize clinical utility and provide easy integration into routine clinical practice. Phase I objectives are to develop and pilot test an outpatient instrument with items for severity adjustment, develop and validate inconsistent and malingering response scales, and derive a brief scale for use in seamless (across setting) monitoring. PROPOSED COMMERCIAL APPLICATIONS: Applications include clinical decision support, documentation of outcomes, support for CQI, program evaluation, and provider profiling. The market includes organizations which provide or manage outpatient behavioral health services - treatment systems, HMOs, Managed Care Organizations, drug treatment programs, etc.